Defining Protective IgGs to Food Allergy

Project Summary/Abstract
Approximately 2% of the population of Western country is affected by peanut allergies. Peanut oral
immunotherapy OIT has gained traction in the clinic as therapeutic option. However, successful peanut OIT
resulting in tolerance to peanuts, or sustained unresponsiveness, occurs in only 50% of treated individuals. It is
not known why peanut oral immunotherapy (OIT) induces tolerance to peanut some peanut-allergic individuals,
but not others. There are likely multiple contributing factors, including differences in OIT-induced peanut-specific
IgG specificity and affinity, differences in peanut-specific IgG titers, differences in peanut-specific IgE titers, as
well as the variable induction of peanut-specific T regulatory cells. However, a systemic characterization of the
peanut-specific IgG response to OIT has not been conducted. We profiled peanut-specific IgG from peanut-
allergic adults who underwent peanut OIT in PNOIT2 trial. Intriguingly, a signature of peanut-specific IgG was
identified in patients that developed sustained unresponsiveness, or tolerance, to peanuts. Our long-term goal
is to understand how glycosylation regulates antibody effector functions, enabling therapeutic approaches that
modulate antibody glycosylation to tailor effector function accordingly. Our central hypothesis is that allergen-
specific IgG generated during successful OIT preferentially bind activating FcγRs. The rationale for these studies
is that empirically determining the requirements for IgG that are protective against food allergy will enable the
development of novel biologics for food allergies, while extensive characterization of the peanut OIT IgG
response will enable identification of biomarkers that predict the outcome of OIT. We will test our central
hypothesis by pursuing the following specific aims: 1) Define the IgG signatures from peanut OIT that are
associated with OIT outcomes; 2) Determine the requirements for protective IgG during food allergy. Using an
approach that combines biophysics, biochemistry cellular and molecular immunology, and glycobiology, we will
define the allergen-specific IgG response to OIT from two additional clinical trials and test the IgGs that are
identified in functional models of food-mediated anaphylaxis. In addition to enabling discovery of biomarkers
successful peanut OIT, these studies will potential outline the requires for IgG that protect from food allergy.

Public health relevance
Project Narrative. The proposed research is relevant to public health because IgE antibodies that recognize food proteins, including peanuts are a significant burden. Although peanut oral immunotherapy (OIT) has gained traction recently as a therapeutic treatment for peanut allergy, how OIT results in peanut allergy protection is unknown. This project will define the characteristics of IgG that protect from peanut allergy, and is relevant to the mission of NIH because it will generate basic immunology knowledge relating to the role of the IgG and IgE in food allergy, and establish novel biomarkers following OIT.